Flexible Funding Model -MFRPS, RRT, Food Safety Task Force

Project Summary/Abstract
The Texas Department of State Health Services (DSHS) proposes to continue its
mentorship with other states' Rapid Response Teams; coordinate outbreak response with
Food and Drug Administration (FDA) Coordinated Outbreak Response and Evaluation
(CORE) and local health departments that have jurisdiction over retail sales of food;
establish communication protocols with food industries in Texas; further develop
Standard Operating Procedures (SOPs) and embed Texas Rapid Response team
(TRRT) responsibilities into the day to day activities of the state staff. Additionally, DSHS
will undertake a capability assessment each year and develop and update an
improvement plan for the TRRT; schedule and conduct at least one exercise or respond
to an incident, including after action reviews each year, and; represent the TRRT on
national RRT workgroups and at local and national meetings. DSHS will continue to refine
and enhance the development of the Texas Rapid Response Team so that in the event
of a food borne illness outbreak, the TRRT will be able to respond quickly and effectively.
Over the next 5-year grant period DSHS Manufactured Foods Regulatory Program
Standards (MFRPS) proposes to continue work to maintain the standards. In addition,
the program will work on standards enhancement projects outlined in the strategic plan
(Appendix B). The program will participate in the MFRPA Annual meeting and look for
opportunities to participate on national workgroups related to the standards. DSHS will
continue outreach to include specialized training for local health department
epidemiologists in case interviews and developing a protocol for working with local health
departments during food borne illness investigations (Standard 5), on-demand webinars
for industry in areas of GMPs, preventive controls, and common violations (Standard 7),
and providing Preventive Control Alliance training for regulatory and industry partners
(Standard 2 and 7).
The Texas Food Safety and Defense Task Force provides a forum to discuss food safety
and security issues along the farm to fork continuum with a primary focus on Texas. The
purpose of the Task Force is to maintain an open dialogue with all partners in food safety
and defense in order to promote an efficient food safety system in Texas that maximizes
the protection of public health. The Task Force is comprised of academia, industry
associations, consumer associations and regulatory agencies at the local, state, and
federal levels. The taskforce will hold annual meetings.

Public health relevance
Project Narrative The Flexible Funding Model MFRPS, RRT, and Food Safety Task Force project will facilitate the Texas Department of State Health Services’ efforts to protect public health by reducing and preventing instances of foodborne illness and food/feed contamination. Food/feed safety procedures and practices will continue to be regimented and improved thorough shared innovation, effective assessments, coordinated response, and relationship building.